Core D: Administrative Core

Core D, the Administrative Core, will be responsible for continuous, high quality administrative and communication support for the individual research Core. This support will be directed towards the PIs, Core Directors and the UAB Neuroscience Core Center investigators. The Core will determine the overall research direction based on input from the Core Directors, the Center's Steering Committee, and on responses from the investigator base. In executing these functions, the Administrative Core will conduct the day-to-day operations of the Center and provide a multi-faceted infrastructure that accelerates effective, productive neuroscience research.